In vivo imaging of mammalian fertilization

PROJECT SUMMARY/ABSTRACT
The overall objective of this study is to develop a novel imaging technology to directly observe and better
understand multiple aspects of fertilization within the mouse fallopian tube in vivo. This study is aligned with
the NIH mission in Woman’s Health Research established across all NIH Institutes and Centers “to advance
rigorous research that is relevant to the health of women”.
The ovulation, fertilization, and pre-implantation pregnancy are fundamental processes of clinical importance.
However, because mammalian reproductive processes take place deep inside the body, our understanding of
cellular and molecular mechanisms driving reproduction is based on the histology of extracted organs, low-
resolution visualizations, and extrapolation from invertebrate animal models (e.g., sea urchin). The dynamic
environment of the female reproductive tract is too complex to model, and understanding the interplay between
the oviduct eggs, sperm, and the oviduct environment based on in vitro data without direct observation is not
feasible. Therefore, much of our knowledge regarding the dynamics of fertilization and oocyte/embryo transfer
in vivo is based on assumptions thereby limiting the development of infertility treatments and assisted
reproductive technology (ART).
By integrating expertise in live functional optical imaging and reproductive biology, we established a unique
project investigating multiple aspects of fertilization in vivo within the mouse fallopian tube with functional optical
coherence tomography (OCT). We performed the first in vivo tracking of oocytes and embryos within the fallopian
tube and made discoveries that question current views in the reproductive field, setting a foundation for this
proposal. This study is taking advantage of new technological developments in high-speed volumetric
imaging and will allow for quantitative functional analysis of the natural fertilization process and
fertilization failures in mouse models of human infertility. This project will provide new insight into the
process of mammalian fertilization in its native state and lead to a better understanding of pathologies resulting
in infertility. Mouse models provide an irreplaceable resource for healthcare, with thousands of genetic and
epigenetic preclinical models available to study human diseases and an established pipeline for translating the
knowledge from mouse models into clinical practice. This study will also enable the global international effort to
inform human reproductive healthcare strategies through functional phenotyping of hundreds of mouse models
linked to infertility.

Public health relevance
PROJECT NARRATIVE Because mammalian reproduction takes place deep inside the body, the majority of what we know about the dynamics of fertilization and pre-implantation embryo movements is assumed based on histological analysis and extrapolation of studies in invertebrate animal models, limiting the development of infertility treatments, assisted reproductive technology, and contraception. This project utilizes new developments in live high-resolution optical imaging to gain new insights into mammalian fertilization toward functional analysis of fertility failures in preclinical mouse models of human defects.